Novel mechanisms of DNA repair and cell cycle regulation in bacteria

Project Summary:
The long-term goal of this research is to understand the contribution of unstudied genes and
novel mechanisms to genome maintenance in bacteria. A major challenge in medicine today is
addressing the emergence and persistence of antibiotic resistant bacteria. Bacterial species are
able to adapt and cope with unfavorable conditions by regulating growth and their response to
DNA damage. Bacterial cells are constantly exposed to a broad spectrum of DNA damage
caused by intracellular sources, environmental stressors, antibiotic treatments, and disinfectants
applied in domestic and hospital settings. Although genome maintenance has been studied in
some bacteria, far less is known about these processes in Gram-positive bacteria. One major
challenge is that even for the most well studied Gram-positive bacterium, Bacillus subtilis, >40%
of the genes are undefined with the vast majority composed of domains of unknown function.
This lack of knowledge represents a major fundamental gap in our understanding of how
bacteria mitigate stress that affects survival, proliferation, and the acquisition of mutations.
While B. subtilis does not cause disease, its genome maintenance pathways are closely related
to a number of important human pathogens, including Staphylococcus, Enterococcus, and
Streptococcus species which cause hospital-acquired infections imposing a significant
economic burden on our healthcare system. We have employed several large-scale genome-
wide screens to identify numerous uncharacterized genes that are highly conserved among
bacteria and are critical for DNA repair and the regulation of the response to DNA damage. We
have also identified new enzymatic activities for existing proteins that will strongly impact our
understanding of survival to genotoxic agents. We expect that these studies will result in the
complete mechanistic characterization of proteins involved in excision repair, transcriptional
response to DNA damage, and DNA break repair. All the genes we propose to study cause
severe growth defects, or lead to antibiotic resistance when impaired. The strong phenotypes
associated with the deletion mutants underscores these candidates as important targets for the
development of effective antimicrobial intervention efforts.

Public health relevance
PUBLIC HEALTH REVELANCE Proper DNA repair and cell cycle checkpoints are fundamental to cell growth and maintenance of genome integrity in all cells. Defects in DNA repair can cause mutations and genomic rearrangements changing the rate of cell proliferation leading to cancer in humans and antibiotic resistance in bacterial pathogens. The mechanisms of antibiotic resistance we propose to study are conserved in several bacterial pathogens that are important contributors to hospital-acquired infections and represent significant healthcare and economic burdens in the United States.